Evaluating the social influences that impact vaccination decisions

We will apply transdisciplinary, data-driven and multi-scale modeling approaches to inform timely policy decisions. We will specifically evaluate the effectiveness and cost-effectiveness of vaccination strategies to control rabies, polio and pertussis. Our models will capture epidemiological, clinical, behavioral and socio- economic factors pertinent to the implementation, effectiveness and health economics of policy decisions. Our results will enhance our understanding of health decision-making and inform intervention strategies to improve vaccination rates nationally and internationally.

Public health relevance
We will develop data-driven transmission models to address public health challenges regarding a range of infectious diseases, including rabies, pertussis, polio and HIV.